Preteen Suicide Risk and Protective Factors Data Coordinating Center

PROJECT SUMMARY/ABSTRACT
Suicide is a leading cause of death among youth ages 8–12 years, and rates of suicide in children are
increasing. Alarmingly, suicide increased 87% among youth ages 10–14 from 2000 to 2021 and 49% among
those ages 15–24. The National Institute of Mental Health (NIMH) will support a Consortium of six research
projects and a data coordinating center (DCC) to improve understanding of risk and protective factors related
to preteen suicidal thoughts and behaviors for a range of youth. We recognize that this important and complex
endeavor requires exceptional coordination across a range of activities inherent to a multi-site Consortium as
well as expertise in data harmonization, integration, and a multidisciplinary lens. RTI proposes to serve as the
DCC for this Consortium of investigators. In this capacity, RTI will facilitate data coordination by assisting the
Consortium in developing common measures and metrics and in establishing common data formats, data
structure, and data-sharing processes (Aim 1). RTI will also facilitate scheduled data monitoring and analysis
as well as dissemination of Consortium results (Aim 2). RTI will promote research efficiency and foster
collaboration by establishing a centralized structure for scientific, administrative, and logistical operations (Aim
3). Finally, RTI will maximize the scientific impact of Consortium data by facilitating data sharing and
developing best practice guidelines to optimize use of the data by the broader scientific community (Aim 4).
Our DCC team will be led by a developmental psychopathologist with extensive data coordination experience,
data integration and harmonization science. The broader team will comprise experienced leaders of multi-site
studies and experts in consensus building, data harmonization, and preteen suicidal thoughts and behaviors
for this age group. Core leaders, key staff, and consultants will bring robust data harmonization and data
science approaches interwoven with a deep understanding of preteen suicide and suicide multidisciplinary
science. We offer proven computational infrastructure and statistical expertise to support all the required data
management and analysis needs for the Consortium. RTI will back this project with its unsurpassed experience
and proficiency, born from successful leadership of over 40 other coordinating centers, to support and
accomplish these aims. Collectively, we are well prepared to help NIMH and the Consortium to produce data
and best practices for the research community studying preteen suicide risk and protective factors across
developmental trajectories that are sensitive to all youth

Public health relevance
PROJECT NARRATIVE The Preteen Suicide Risk and Protective Factors Data Coordinating Center (DCC) will work with six research projects to agree on and publish common data elements designed to help researchers identify factors that put children ages 8–12 at risk for suicidal thoughts and behaviors. The DCC will help coordinate information produced by these research projects to make data available for other researchers through the National Institute for Mental Health Data Archive.